Pseudomonas aeruginosa heme sensing inhibitors targeting HasAp

PROJECT SUMMARY
Multidrug-resistant (MDR) Pseudomonas aeruginosa (Pa) is responsible for ~10% of nosocomial infections,
highlighting the critical need for the development of novel therapeutic approaches. The Wilks Lab has shown
that chronic Pa lung infection isolates from cystic fibrosis patients decrease the reliance on iron-siderophore
uptake over time, while increasing the reliance on heme. Our genetic and biochemical analysis characterized
the Pa Has and Phu systems as having non-redundant roles in heme transport and sensing, respectively.
Transcriptomics showed mRNA levels of the extracellular hemophore hasAp and its outer membrane receptor
hasR are the most significantly upregulated genes in an acute murine lung infection model. In the same model,
a ∆hasR strain showed significantly reduced growth and virulence. Moreover, formulations of the redox inactive
metal gallium (e.g., Ganite) have been clinically used as antimicrobials by targeting iron uptake systems. Our
preliminary studies have shown that the stable gallium-salophen complex, GaSal, binds to HasAp and blocks
the heme-signaling cascade, decreasing the ability of Pa to sense and utilize heme. At the same time, GaSal
functions as a xenosiderophore for the siderophore uptake systems of Pa, leading to intracellular dysregulation
of iron homeostasis. Our central hypothesis is that simultaneous inhibition of Pa heme sensing by targeting
the extracellular hemophore HasAp while optimizing xenosiderophore receptor uptake is a novel strategy for the
treatment of Pa infections. Our goal is to synthesize a series of GaSal analogs and test them using established
assays, to identify, validate, and characterize potent inhibitors of heme signaling and iron homeostasis. To
achieve our goal, we will synthesize new GaSal analogs that have been designed using a novel computer-aided
drug design (CADD) methodology SILCS (Aim 1). The synthesized compounds will be subjected to the FQ assay
to determine their affinities to HasAp. Selected inhibitors will be further assessed for inhibition of heme signaling
and uptake using transcriptional reporter assay and 13C-heme LC-MS/MS assay, respectively. GaSal uptake by
siderophore receptors will be quantified by measuring the intracellular Ga levels using ICP-MS. In Aim 2, we
will determine MIC50 and biofilm inhibition of selected compounds on a panel of Pa strains. For the top
candidates, we will further test their in vivo efficacy in C. elegans. The HasAp binding epitope of top compounds
will be determined by STD-, HSQC-NMR and HDX-MS. Our collaborative research team has a strong track
record of performing CADD, hit-to-lead optimization, and in vitro and in vivo evaluation of compounds.
Collectively, our approach puts us in a unique position to identify, validate, and characterize first in class small
molecule with dual activity of inhibiting heme signaling cascade and mimicking the substrate of siderophore
receptor of MDR Pa, and to determine whether this novel mechanism of action is a viable option for the
development of antimicrobials.

Public health relevance
NARRATIVE Multidrug-resistant (MDR) Pseudomonas aeruginosa (Pa) is responsible for ~10% of nosocomial infections, highlighting the critical need for novel approaches to be used alone or in combination with current antibiotics. We have synthesized and characterized a novel gallium salophen complex GaSal that blocks the heme-signaling cascade, decreasing the ability of Pa to sense and utilize heme, while also acting as a xenosiderophore leading to intracellular dysregulation of iron homeostasis. Our goal is to synthesize and test a series of GaSal analogs using established assays, to identify, validate, and characterize potent inhibitors of heme signaling and iron homeostasis.